ASSESSMENT OF DAYTIME SLEEPINESS BEFORE AND AFTER LIGHT EXPOSURE

This study was designed to investigate whether an increase in circadian rhythm amplitude accomplished through exposure to bright indoor light during the morning hours causes a concurrent decrease in daytime sleepiness. The multiple sleep latency test(MSLT) and subjective measures of alertness will be used.